Epidemiological analysis of two interstitial cystitis cohorts

PROJECT SUMMARY/ABSTRACT
Interstitial cystitis/bladder pain syndrome (IC/BPS) is a multifactorial, chronic syndrome involving urinary
frequency, urinary urgency, and bladder discomfort (1) that affects an estimated 10 million patients in the
United States(2). Although understandings of IC/BPS pathophysiology remain limited, published studies
have found several comorbidities, including vulvodynia and anxiety comorbidities prevalent in IC/BPS (4, 5).
Research suggests that these comorbidities, in turn, exacerbate IC/BPS symptoms and are associated
with poor functioning, adjustment, prognosis, and treatment response rates.
The research within this proposal builds upon our previous analyses and those of the Multidisciplinary
Approach to the Study of Chronic Pelvic Pain (MAPP) Research Network. Our cohort of 400 IC/BPS
patients at Boston Children's Hospital has been followed for 15 years and provides an extraordinary
opportunity for an epidemiological study of the various conditions co-occurring with IC/BPS.
We will also comprehensively phenotype a large online cohort of patients with IC/BPS through surveys
and systematic analysis of patient social media posts via “social listening”, which could be
methodologically advantageous in identifying environmental factors when triangulated with patient
surveys influencing IC/BPS comorbidities.
The hypothesis underlying this proposal is that extensive phenotyping will elucidate the depth and breadth
of co-occurring disorders in IC/BPS and uncover factors that play a role in the development of the
disorders. Based on this hypothesis, our aims are to: 1) identify the prevalence of conditions in
demographically distinct cohorts (e.g, anxiety, depression, vulvodynia) and potential environmental
influencers (e.g., family discord, poverty, pollution); 2) comprehensively and rigorously phenotype a subset
of these patients with the use of PROMIS and PhenX toolkit surveys for comorbid conditions; and 3)
characterize the impact of health disparities on IC/BPS, with particular attention paid to health disparities
affecting African Americans with IC/BPS. As this project leverages existing cohorts and conducts
phenotyping via telemedicine, it is a cost-effective approach to better characterizing phenotypes and
elucidating the architecture and epidemiology of dimensional phenotypes in IC/BPS.

Public health relevance
PROJECT NARRATIVE Interstitial cystitis/bladder pain syndrome (IC/BPS) is a multifactorial, chronic syndrome involving urinary frequency, urinary urgency, and bladder discomfort that affects an estimated 10 million patients in the United States. Through the proposed comprehensive surveying, interviewing, “listening” to social media posts, rigorous phenotyping, and investigating the impact of health disparities in two cohorts (one, an online community of 20,000 patients, and the other a cohort of 400 individuals followed at Boston Children's Hospital), the outcomes of this study will lead to better understanding of the epidemiology and comorbidities of IC/BPS.